IRON K-BETA XES STUDIES OF THE NITROGENASE ENZYME SYSTEM AND MODELS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. K-beta XES data have been obtained on a series of Fe(II) and Fe(III) model complexes in order to develop an understanding of the changes which occur in the Kbeta1,3 (3p-1s) and Kbeta2,5 (valences to 1s) emission spectra as a function of spin state, oxidation state and local structure. Of particular interest are the Kbeta? crossover features which are empirically correlated to a ligand 2s to 1s transition, and as such may be used to differentiate carbon from nitrogen from oxygen. Analyses of these data are currently underway. In addition, preliminary data on the MoFe protein of nitrogenase and the delta-nifB mutant have been obtained and demonstrate the feasibility of these methods for investigation of dilute protein systems.